Bioinformatics

BIOINFORMATICS CORE SUMMARY/ABSTRACT
In the previous phase of SD BRIN, the Bioinformatics Core team proposed the following primary goals: 1)
provide online library resources; 2) provide comprehensive bioinformatics educational resources and
opportunities; 3) support individual research projects; 4) support collaborative, multidisciplinary research,
5) facilitate data management, and 6) maintain and enhance the University of South Dakota’s research
cyber-infrastructure. Note: Our original BRIN proposal described a Bioinformatics Core collaboration with
University of Nebraska Omaha. Due to administrative changes in the UNO BRIN program, the Bioinformatics
Core instead, developed a strong collaboration with the South Dakota NSF EPSCOR project.